Driving Performance after Stroke: Impact of Cognition, Lesion Site, and Driver-Assist Features

Chronic disability following stroke is a significant problem for Veterans affecting a variety of daily activities. One
area of importance is the impact of stroke on driving safety. With technology for fully autonomous driving vehicles
still decades away from implementation, it is critical that we ensure a safe return to driving in our Veterans
following brain injury. Evaluation of Veterans’ driving skills in a driving simulator is a safe and low-cost procedure
that has been shown to correlate highly with on-road testing. In our prior Merit project, we have established that
stroke patients with a wide range of deficits can successfully complete simulated driving assessments and we
have shown that brain injuries involving the left versus right cerebral hemisphere result in very different patterns
of driving errors (e.g., lane deviations, collisions, and speeding). We also found that measures of executive
functioning and visuospatial abilities are more predictive of driving performance than other factors such as age,
visual acuity, and simple reaction time. Our data thus far suggest a need for driving evaluations that can target
specific driving skills related to specific cognitive abilities, a key step towards the goal of precision-medicine at
the VA, which strives to tailor care and treatment to the specific needs of individual patients.
The current project will address this need by evaluating stroke patients on a state-of-the-art driving simulator in
which specific driving skills (lane positioning, speed management, and accident avoidance) will be individually
assessed in separate driving modules. These specific driving skills will be related to performance on cognitive
tasks in order to identify which cognitive functions are consistently associated with specific aspects of driving. In
addition, we will examine whether several common driver-assist features (e.g., lane departure and collision
warnings) are helpful or harmful to individuals recovering from stroke. Lastly, we will investigate the neural
correlates of specific driving skills using lesion symptom mapping techniques, which relate specific brain regions
to behavioral performance. Participants will include 40 left and 40 right hemisphere Veteran stroke patients with
no prior neurologic or severe psychiatric history, and 20 age- and education-matched Veterans with no
neurologic or psychiatric history (controls). We will use a state-of-the-art driving simulator that has been
demonstrated to have strong ecological and predictive validity with respect to on-road driving fitness. It is
predicted that left hemisphere stroke patients will exhibit greater impairment in speed control and that
performance on this skill will correlate with attentional monitoring capacity and executive functioning measures
(e.g., Trailmaking). Right hemisphere stroke patients, in contrast, are predicted to have greater difficulty with
lane positioning and collision avoidance, which is expected to correlate with visuospatial attention bias and
spatial working memory capacity. It is further expected that Veterans with posterior right hemisphere strokes will
benefit from driver assist warning signals that help “direct” their attention, while these same signals are expected
to be detrimental to left hemisphere patients with decreased executive functioning and limited attentional
resources. With respect to lesion site, it is predicted that specific driving skills related to visuospatial attention,
such as lane positioning, will be associated with lesions in dorsal fronto-parietal cortex, whereas driving skills
requiring sustained visual monitoring, such as speed management, will be associated with lesions to a ventral
network in left inferior frontal and temporal cortex.
The proposed study will advance the field by identifying neuropsychological measures and biomarkers that can
be used clinically as a preliminary screen to identify driving vulnerabilities. It is our goal that this study will also
be a first step toward the development of individualized driver training programs at VA that can be implemented
in a safe and low-cost simulated driving environment to assist brain injured Veterans safely return to driving.

Public health relevance
Stroke affects nearly a million Americans every year and thousands of Veterans. Unfortunately, many individuals do not fully recover from stroke, leaving them with numerous deficits that affect their daily lives. These deficits can include changes in visuospatial and cognitive functioning, which are critical for daily activities such as driving. Many stroke patients, however, return to driving without ever receiving a thorough assessment of visuospatial abilities and/or a formal driving evaluation. In the current study, we are proposing to relate cognitive functioning and stroke lesion sites to specific driving skills using a driving simulator. Our main goals are to identify cognitive deficits (behavioral markers) and brain regions (biological markers) that are consistently related to different aspects of driving. We will also investigate the usefulness of driver hazard warnings in driving after stroke. Findings from this project will help identify the most important aspects of cognition and driving to target in future efforts to rehabilitate brain injured individuals who wish to return to driving.